Corticolimbic Neuroimmune Determinants of Social Stress-Associated Alcohol Drinking

PROJECT SUMMARY
Social stress is a prevailing factor in the lives of all social species and can motivate the misuse of reinforcing
drugs such as alcohol. Individuals that use alcohol to alleviate the negative emotions created by social stress
are more likely to develop pathological drinking patterns, which can lead to an alcohol use disorder (AUD).
Indeed, an individual’s standing in a social hierarchy (i.e. social rank) is inversely related to alcohol
consumption in rodents and non-human primates as well as problematic drinking in humans, highlighting the
conserved impact of subordination stress on motivation for alcohol. Social rank also influences how individuals
respond to challenges, and social isolation is a particularly profound stressor with increasing human relevance.
Our preliminary data identify a previously unknown relationship between mouse social rank and isolation-
associated escalated alcohol drinking, where subordinates display a greater magnitude increase in drinking
following social isolation compared to dominants. These data suggest that low social rank may be a potent risk
factor for developing pathological alcohol drinking patterns. Understanding the neurobiological mechanisms by
which social stress experiences engender aberrant alcohol drinking could have important translational
implications for AUD. It is becoming increasingly evident that social stress induces microglia-mediated
neuroimmune responses in select stress-responsive brain regions, including the basolateral amygdala (BLA)
and medial prefrontal cortex (mPFC), which contribute to stress-induced behavioral adaptations. Notably,
social isolation-induced escalation of alcohol strongly parallels increases in microglia previously seen following
social stress, supporting a potential role for microglia in isolation-induced adaptations in alcohol drinking.
Despite the substantial evidence linking social stress and alcohol drinking as well as the impact of social stress
on neuroimmune signaling, virtually nothing is known regarding the neuroimmune regulation of circuits
underlying social stress-induced behavioral adaptions in alcohol drinking. To fill this gap, this proposal will test
the central hypothesis that social stress activates microglia-mediated neuroimmune signaling, which re-shapes
amygdalar-cortical circuits underlying escalated alcohol drinking. Preliminary data show that social isolation
increases BLA excitability, and the BLA-mPFC circuit regulates alcohol drinking. Dr. Patel will use her new
training in advanced circuit imaging and dissection technologies and previous training in cell type specific
transcriptomic analysis and ex vivo electrophysiology to 1) dissect the BLA-mPFC contribution to social rank-
and isolation-induced alcohol drinking, 2) delineate the impact of BLA substrates on mPFC encoding of alcohol
consumption, and 3) identify social stress-induced neuroimmune determinants driving circuit adaptations
underlying aberrant alcohol drinking. In executing the proposed experiments and professional development
plan, Dr. Patel will be well-positioned to transition to a tenured-track faculty position and establish an
independent research program centered around neuroimmune and social stress regulation of circuits in AUD.

Public health relevance
PROJECT NARRATIVE Human socioeconomic status is one of the strongest predictors of health and mortality, however little is known regarding the neurobiological mechanisms predisposing individuals of low social status to neuropsychiatric disorders such as alcohol use disorder. This proposal will uncover neuroimmune and circuit determinants underlying mouse social rank-dependent differences in escalated alcohol drinking following a social isolation challenge, a profound stressor with increasing human relevance. The findings will advance our conceptual framework for neuroimmune regulation of circuits underlying social stress-associated alcohol drinking and potentially identify specific neuroimmune targets to inform therapeutic intervention, to ultimately narrow health disparities in AUD.